The Celiac Disease Genomic, Environmental, Microbiome, and Metabolomic (CD-GEMM) Prospective Cohort Study

ABSTRACT
Our proposed multidisciplinary investigations have the long-term objective to identify and validate specific
microbiota and metabolomic profiles that can predict loss of tolerance in infants genetically at risk of
autoimmunity in order to implement early preventive interventions to re-establish tolerance and ultimately prevent
autoimmunity. We have focused our research effort on celiac disease (CD), a unique model of autoimmunity for
which the triggering environmental factor (ingestion of gluten containing grains), a close genetic association with
HLA genes (DQ2 or DQ8) and a highly specific humoral autoimmune response (autoantibodies to tissue
transglutaminase) are known. Our recent studies have subverted the previous notion that loss of gluten tolerance
occurs at the time of its introduction in the child's diet; rather it can occur at any time in life as a consequence of
other environmental stimuli. Our preliminary data also suggest that gut microbiome composition and consequent
changes in specific metabolic pathways precede the onset of the disease and may contribute to switching from
tolerance to immune response to gluten. To achieve our objective, we will capitalize on our unique birth
prospective cohort of infants at-risk of CD to compare microbiome, metabolome, and immune profiles of children
who will develop CD with age- and sex-matched controls (both HLA DQ2/DQ8 negative and positive infants who
did not develop the disease) in order to address three specific aims. With Aim 1, we propose to maintain the
infrastructure and maximize surveillance of the existing prospective cohort of infants at-risk for CD with the goal
of studying genome, metagenomic, metabolomic, and immune profiles of CD in at-risk infants to define the multi-
omics makeup associated with the development of CD autoimmunity. With Aim 2, we will investigate the
molecular and functional effects of specific gut microbes and metabolites found altered in our preliminary studies
on gluten-induced mucosal innate immune response by using co-cultures of gut organoids and macrophages
from children who developed CD. With Aim 3, we will use multi-omics statistical analysis and machine learning
to identify microbiome biomarkers of CD and to construct an inclusive model that integrates omics and
meta’omics data from the host and microbiota as well as clinical metadata in order to predict the chance of CD
development in at-risk children. Overall, the outcome of our studies may have far-reaching impact not only on
CD, but also on other autoimmune diseases in which the diet-genome-microbiome interaction in the
pathogenesis of the disease has been hypothesized. Since in the U.S. almost 3 million people are affected by
CD and approximately 17 million people suffers of other autoimmune diseases and that currently there are no
effective strategies to prevent these conditions, this project can potentially have a tremendous impact on public
health.

Public health relevance
PROJECT NARRATIVE The paramount goal of this proposal is to identify and validate specific genetic, immune and gut microbiota and metabolomic profiles that can predict the loss of gluten tolerance in infants at risk of CD. This is instrumental for designing early intervention strategies to prevent autoimmunity in childhood through manipulating the gut microbiota features that are linked to the host immune system and maintain tolerance to gluten.